Visualizing hierarchical processing of photic input to the circadian clock in vivo

Project summary / Abstract
A fundamental property of neural systems is the capability for functional adaptation in response to the signals they re-
ceive. Though much has been learned using existing approaches, a major limitation in investigations of neural circuits has
been the need to section the brain, destroying most of the network, and divorcing it from its sensory inputs or behavioral
outputs. The mammalian circadian system, including the hypothalamic suprachiasmatic nucleus (SCN), is one such cir-
cuit, unique in that represents a well-defined population of cells that engage in a full suite of functions that typify an entire
nervous system: the network is affected directly by sensory input which is easily manipulated, processes such input to
alter its function, and generates outputs that directly impact behavior. The overall goal of our research program is to un-
derstand how the brain processes sensory light input, integrates that input into the ongoing circadian behavioral/regulatory
program, and generates outputs that regulate behavior and physiological activity. We propose that it is a process involving
hierarchical plasticity, where sensory neurons in the eyes affect the internal clock time of primary oscillator neurons,
which then act on secondary and tertiary systems within the brain to alter global physiology and the timing of sleep/wake.
With in vivo widefield fluorescence imaging using a miniaturized microscope, this circadian neural network can now be
observed in real time during responses to environmental input, goal-directed behaviors, and abnormal function. This ap-
proach provides unprecedented anatomical and phenotypic specificity and can be applied over short (seconds-minutes)
and long (weeks-months) timescales. Our research program comprehensively attacks a range of important systems-level
features of circadian biology which were previously not addressable: cell-type specific acute response to systemic input
(light), the on-going network level processing that occurs in response to that light input, and how those mechanisms begin
to fail with aging. Such studies of hierarchical processing of sensory input, leading to systems-level plasticity and behav-
ioral change, followed over long timescales will pay dividends in understanding the steady-state and aging mammalian
nervous system as a whole.

Public health relevance
Project Narrative / Relevance The circadian clock in the hypothalamic suprachiasmatic nucleus (SCN) of the mammalian brain is a compact neural net- work which can be studied as a simplified model of the entire central nervous system. A major limitation in investigations of neural circuits to-date has been the need to section the brain, destroying most of the network, and divorcing it from its sensory inputs or behavioral outputs. We propose to employ in vivo real-time Ca2+ imaging in the SCN to study cell-type specific rhythmic generation, the network processing of light input that leads to changes in the circadian behavioral rhythm, and how these mechanisms falter during the process of aging.